Administrative Supplement to Cognitive Resilience among Older Samoans

PROJECT SUMMARY
This proposed administrative supplement to collect new biomarkers could increase the scientific
knowledge related to cognitive resilience gained from our current NIA-funded R01 entitled, “Cognitive
Resilience among Older Samoans.” This supplement builds on recent developments that were unforeseen
when we submitted the parent R01: (1) it was discovered that a genetic variant associated with longer telomere
length (rs28372734) appears more than twice as frequently among Samoans than any other population
studied; and (2) we found that our parent grant’s genetic predictor, the Pacific-Islander-specific gene variant
CREBRF (rs373863828) predicts lower perceived stress in our parent R01 sample. As longer telomere length
and lower stress are associated with cognitive resilience, assessing the telomere-length gene variant and
stress biomarkers will allow us to determine whether these factors contribute to the mechanism by which
Samoan older individuals achieve cognitive resilience. The 2 stress biomarkers that represent 2 pathways
through which lower stress can benefit brain health are: (1) lower chronic inflammation, as indicated by lower
CRP levels; and (2) better T-cell functioning, as indicated by lower Epstein Bar Virus (EBV) antibody levels.
Thus, leveraging the strong infrastructure and enrolled sample of 600 older Samoan persons that we
are following over 3 years in our parent R01, our supplement’s specific aims are to examine for the first time
whether: (1) the telomere-length gene variant predicts cognitive resilience; (2) lower inflammation (as indicated
by lower CRP levels) mediates the parent R01’s predictors’ (the CREBRF variant and Samoan positive age
beliefs) association with cognitive resilience; and (3) adaptive T-cell function (as indicated by lower EBV
antibody levels) mediates the association of the parent R01’s predictors with cognitive resilience.
This proposed supplement addresses the goals of the 2022 National Plan to Address Alzheimer’s
Disease3 which points out that because there are no interventions known to definitely prevent, treat or cure
ADRD, there is a need to identify “the genetic underpinning of ADRD” and “the role of immunity and
inflammation,” which can be impacted by stress. Further, by studying these factors in older Samoans in the US
and Independent Samoa, we would contribute to NIA’s goals of increasing the study of cognitive resilience
among racial and ethnic minorities in the US as well as individuals in low- and middle-income countries.
By focusing on older Samoans, a group which has unique genetic and cultural qualities, this
supplement could identify a new biological causal pathway to cognitive resilience that is likely to lead to future
interventions for benefitting the Samoan community as well as all older persons.

Public health relevance
PROJECT NARRATIVE The proposed administrative supplement to our parent grant entitled, “Cognitive Resilience among Older Samoans” builds on 2 developments that were unforeseen when we submitted this grant: (1) a genetic variant associated with longer telomere length (rs28372734) was discovered to appear more than twice as frequently among Samoans than any other population studied; and (2) our parent grant’s genetic predictor, the Pacific- Islander-specific gene variant CREBRF was found to predict lower perceived stress in our parent R01 sample. Building on our strong infrastructure and enrolled sample of 600 older Samoan persons that we are following over 3 years with the support of our parent R01, the supplement will allow us to examine for the first time whether: (1) the telomere-length gene variant predicts cognitive resilience; (2) lower inflammation, as indicated by lower CRP levels, mediates the association of the parent R01’s predictors (the CREBRF variant and Samoan positive age beliefs) with cognitive resilience; and (3) adaptive T-cell function, as indicated by lower EBV antibody levels, mediates the association of the parent R01’s predictors with cognitive resilience. Our research is relevant to the National Institute on Aging’s mission of improving the cognitive health of older persons by examining novel mechanisms that may determine cognitive resilience in diverse cohorts.